RACIAL AND GEOGRAPHIC DIFFERENCES IN OCCURRENCE OF NEUROLOGIC DISEASE

The purpose of these studies is to accurately document possible racial, environmental and geographic differentials in the prevalence of major neurologic disorders by surveying an entire geographically defined population. The disorders investigated included cerebral palsy, dementia, psychomotor delay, epilepsy, Parkinson's disease, essential tremor, multiple sclerosis, and cerebrovascular disease.